Neuromodulator signaling and activity in the C. elegans egg-laying circuit

Per guidelines, summary of the funded parent award is included in the Research Plan.

Public health relevance
Project Narrative This proposal aims to understand in unprecedented detail how medically-important neuromodulators, including serotonin, help generate the dynamic pattern of activity in a neural circuit. Defects in neuromodulator function appear to underlie many human brain diseases, such as mood disorders and Parkinson's disease, yet it is difficult to understand these diseases because we as yet have little understanding of how neural circuits work. By deeply studying one neural circuit in the simple model organism C. elegans that uses the same types of neuromodulators found in the human brain, we hope to spearhead a new level of understanding of neural circuit activity that will advance our understanding of neuromodulators and their roles in brain disorders.